Biology of Aging and Age-Related Diseases

Project Summary
Funded by NIA since 1991, this application seeks the 7th competitive renewal for a highly successful T32 program
at the University of Wisconsin-Madison (UW). It requests support for 4 predoctoral and 4 postdoctoral trainees
in aging biology and translational gerontology research. The major mission of this T32 is to provide
interdisciplinary, state-of-the-art training to talented pre- and post-doctoral fellows in basic biological and
translational/clinical research in aging and related diseases. In keeping with our track record, it is projected that
the majority of trainees in the next funding cycle will pursue successful academic careers, and lead prominent
programs in aging research across the country. This application builds upon the remarkable resources of UW in
gerontology research and includes 39 (20 women and 19 men) faculty mentors with acknowledged expertise in
aging research. Notably, the mentors are balanced across the three faculty ranks of Professor (20), Associate
Professor (12) and Assistant Professor (7), and each mentor has a celebrated history of conducting NIH- or other
peer-reviewed source-funded cutting-edge research in aging and training successful scientists in gerontology.
For over 32 years, this T32 has received substantial institutional commitment. The present application includes
significant financial commitments, including support for a (i.e., 5th position) predoctoral position each year, funds
to cover 10% effort for both the Program Director and Co-Director annually, and salary support to cover 25%
effort for a T32 Administrator. Additional strengths of this application include: 1) inclusion of 14 (36%) new faculty
mentors representing emerging areas in aging and translational research; 2) balanced distribution of mentors
between early-stage, mid-career, and established faculty ranks; 3) history of over 87% of T32 trainees supported
over the past 15 years pursuing successful research-related careers; 4) notable accomplishments by trainees
with each publishing peer-reviewed papers, presenting preliminary findings at local or national meetings, and
attending courses as necessary; 5) enhanced efforts to increase recruitment and retention of trainees from
underrepresented groups; and 6) inclusion of an outstanding training curriculum in both basic biological and
clinical research with the addition of new teaching programs.
Overall, the present T32 will continue to provide outstanding training to talented young scientists in both
laboratory-based and clinical/translational research in aging and related diseases, and help them launch
successful, independently funded academic careers in gerontology.

Public health relevance
Project Narrative The major mission of this T32 is to train dedicated, motivated, and well-qualified predoctoral and postdoctoral fellows in aging biology and translational gerontology research. Given the projected increase in the number of older adults living in the US by 2050, it is critical that significant advances be made toward understanding the biology of aging and related diseases, and that these findings translate into enhanced care of older patients. The present T32 Program will provide state-of-the-art training in aging biology research to talented scientists, preparing them for academic careers at institutions throughout the country and equipping them to make novel contributions toward understanding the biology and enhancing management of disabling diseases of aging.